Center for the Study of Aphasia Recovery (C-STAR)

Project Summary/Abstract
The Center for the Study of Aphasia Recovery (C-STAR, P50-DC014664) explores recovery from language
impairments following stroke. We have expertise using brain imaging and behavioral measures to identify risk
factors for recovery. Stroke is influenced by the climate, with increased incidence both in the summer months
as well as in warmer regions such as the `Stroke Belt` of the United States. For the first time ever, this
proposal will allow us to examine the relationship between climate and 1) patterns of brain injury (location and
extent) in stroke, and 2) patterns of behavioral impairment following stroke, in both chronic and acute data. We
will examine these questions using archival data from existing acute (N =1500) and chronic datasets (N = 260)
that include demographic, behavioral and brain imaging data points. These data were collected in South
Carolina, which is considered the ‘Buckle’ of the ‘Stroke Belt’, and which may serve as a bellwether for future
global warming. Our planned analyses will provide novel insights into the overall health burden of summer
strokes, which requires us to determine whether additional strokes observed in the summer months lead to
long-term impairment or are associated with smaller injuries where symptoms resolve spontaneously. We will
pursue two archival analyses to resolve these questions.

Public health relevance
Project Narrative This proposal will investigate how climate impacts stroke injury and impairments. Previous work has identified that ischemic strokes are more common in the summer months. We will extend this work to identify seasonal variation in stroke risk factors and consequences. We will examine these effects both acutely at hospital admission, as well as in individuals with chronic aphasia.